UNIFIED NCATS AUTH (UNA) MANAGED SERVICE

The National Center for Translational Sciences (NCATS) Information Technology Resources Branch (ITRB) requires:

a. Contractor managed operations services for the Unified NCATS Auth (UNA) authentication and authorization service,
b. Contractor services for application maintenance and development for the UNA service,
c. Contractor support for helpdesk and related end-user support for UNA. The Contractor shall provide end-to-end support for the UNA managed service.